Comprehensive Characterization of Adaptive Regulatory Variation Linked to Human Disease

Project Summary/ Abstract
Over the past decade there has been a rapid expansion of genome-wide association studies (GWAS),
as well as the development of large-scale consortia like the UKBioBank and the All of Us project. While the
number of genetic associations to human traits and disease is soaring, tools to characterize and interpret these
variants are lacking. One challenge to realizing the potential of genomics is that over 99% of human genetic
variation is non-coding, regulatory sequences. However, ‘regulatory grammar’ – the complex pattern of
sequences that interact with transcription factors to control gene expression, is poorly understood. A repertoire
of well-characterized causal variants is needed to build generalizable models with which to unlock insights into
the genetic basis of human health and history.
Natural selection is a powerful driver of human genetic variation. As our species has encountered new
climates, dramatic alterations in diet, and novel pathogens, these selective pressures have left hundreds of
signatures of adaptation in our genomes, reflected in our species’ diversity of disease risk and morphology. For
selection to have acted positively on them, these adaptive alleles must exhibit relatively strong phenotypic
effects, and they continue to contribute to modern traits and disease (e.g. height or sickle cell anemia). Salient
examples of human adaptation include immunity, metabolism, and morphology, all of which have extensive,
unresolved GWAS signals. This renders the lens of recent evolution a powerful, but underutilized, tool for
identifying alleles that contribute to phenotypic variation in modern association studies.
This proposal aims to expand the repertoire of well-characterized GWAS signals, by A) using evolution
to prioritize adaptive variants, and B) applying novel, high-throughput experimental and computational tools to
comprehensively decipher the functions of regulatory variants. These approaches will identify much needed
causal variants, devise paradigms for their study, and inform future predictive models to characterize them.
During the mentored phase of the K99, I will first develop methods to colocalize signals of selection and GWAS,
and then use Variant Effect Predictions (VEP) to predict their function. I will then employ high-through methods
such as a the massively parallel reporter assay and CRISPR non-coding screen to functionally characterize them
directly. From the adaptive GWAS alleles our screens identify, we will make in-vivo system to more deeply
characterize them during the Independent R00 phase. During this time I will deploy a variety of genomic tools
such as ChIP, ChIA-PET, and RNA-seq to understand the adaptive variants’ molecular etiology. I will use the
empirical data fro these studies, and the MPRA/HCR-FlowFISH screens to build more accurate VEP models.
!

Public health relevance
Project Narrative While thousands of genomic regions have been linked to human evolution and diseases, many of the genetic variants responsible are non-coding and thus difficult to interpret. I propose to identify adaptive human alleles underlying genome wide association studies and comprehensively characterize them using novel computational and experimental tools. I will then make in-vivo models of these to test their function and effects on fitness, improving future predictions of how genetic variants impact human evolution and health.